Administration Core

SUMMARY: CANCER CENTER ADMINISTRATION
Dartmouth Cancer Center (DCC) Administration bridges the Geisel School of Medicine at Dartmouth College (Geisel) and Dartmouth Health (DH). DCC Administration was rated “Exceptional” in 2019 and since then has retained senior leaders, recruited experienced successors as needed, and expanded the collaborative team into new CCSG responsibilities. Administration has taken central accountability for a year-long process to assemble the current CCSG application, including new reporting on the Shared Resource Management component. Centrally, Administration also had the lead role in securing 17 P30 CCSG supplements during the last 4 years. It also maintains an IT network that had a lead role in the DH conversion of its Clinical Trial Management System (from Velos eResearch to Advarra OnCore). Implementation of a Center-wide order entry and charge entry system (RaDar) has facilitated reporting of Shared Resource utilization. DCC has administrative responsibility for management of the Rubin building on the DH Lebanon campus. DCC has been delegated institutional lead responsibility for cancer-specific (e.g., Office of Clinical Research) as well as generic resources (e.g., glass- washing) needed by cancer researchers on a shared basis. DCC Financial Administration provides budgeting for both Geisel (e.g., subvention) and DH (e.g., strategic) operating general ledger accounts, including those established for DCC-led Shared Resources and the DCC Office of Clinical Research chargeback service centers, and prepares quarterly reviews of financial performance, as well as end-of-year reconciliation. While all DCC faculty have a primary academic appointment in a Dartmouth department, DCC has lead responsibility for 13 faculty, where DCC had the lead role in their recruitment and houses their activity within its Rubin building. In addition to the CCSG, its supplements, and the faculty for which DCC has a lead administrative role, Administration supports multi-investigator grants administration, such as securing National Clinical Trial Network funding as a Lead Academic Performance Site (LAPS) and designation in the latest award period as a site for the NCI Experimental Therapeutics Clinical Trial Network (ETCTN). Administration continues to have lead responsibility for management of Cancer Center pilot projects secured through twice-annual solicitations, as well as the competitively renewed ACS-IRG. Administration centrally manages a membership process that reaches across both parent institutions, by which Program Leaders nominate Member candidates, Leadership recommends appointments, and the Director approves requests and notifies nominees. Administration is responsible for organizing and supporting a number of standing forums in which DCC decision-making is conducted. Administration has just completed the coordination of a year-long strategic planning process, launched in 2022, to produce an updated 2023–2027 DCC Strategic Plan. Its communication activities, which include maintenance of DCC mailing lists and websites, now have added a new monthly electronic newsletter.